Cardiomyopathy Genomes Project

R01 HL128075 GRANT SUMMARY: As a leading cause of death, heart failure has become a pivotal focal point and increasingly recognized as being under genetic influence. Having a greater understanding of the mechanisms underlying heart failure and cardiomyopathy will improve application of current treatments and stimulate the development of new treatments. Through this work, we are interrogating both coding and noncoding regions for their role in the genesis and progression of heart failure. This diversity supplement is examining mechanisms of FLNC (filamin C) related cardiomyopathy since mutations in FLNC cause cardiomyopathy associated with arrhythmia burden.

Public health relevance
PROJECT NARRATIVE Cardiomyopathy is characterized abnormal heart size and function, and genetic mutations cause multiple forms of cardiomyopathy within families. Genetic mutations causing cardiomyopathy are variably expressed from person to person, and genetic modifiers contribute to this variation. We are defining genetic modifiers for cardiomyopathy to help better diagnose risks and to define pathways that change the course of cardiomyopathy.